CONTROL OF GONADOTROPIN SECRETION DURING LACTATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Lactation is characterized by an inhibition of reproductive cyclicity due to a suppression of gonadotropin releasing hormone (GnRH), excessive hyperphagia and negative energy balance due to milk production. The central hypothesis of this proposal is that suppression of GnRH/LH secretion is due to suckling-induced alterations in hypothalamic neural systems that regulate food intake and energy balance. Our studies have recently established that several hypothalamic neuropeptide orexigenic systems involved in regulating food intake/energy balance (NPY, orexin, melanin concentrating hormone) make direct connections with GnRH neurons, thus providing a neuroanatomical framework by which signals denoting changes in food intake/energy balance can be directly transmitted to GnRH neurons. Using electrophysiological techniques, we showed that NPY has direct inhibitory effects on GnRH neurons;these inhibitory effects are greatly increased during lactation. If the suppressed levels of leptin and/or insulin were restored to normal postlactation levels , there is no effect on the hyperphagia or the suppressed LH secretion during lactation. These results suggest that the negative energy balance of lactation is not a prerequisite for the hyperphagia or the suppression of GnRH/LH. The interaction between reproductive function and energy balance during lactation provides a physiological model for studying a number of conditions in women (undernutrition, anorexia nervosa, bulimia and exercise-induced amenorrhea) that involve a suppression of reproductive function associated with changes in energy balance. The results of the studies formed the basis of a new funded project to study control of food intake in the rhesus monkey.